The Impact of Maternal and Paternal Preconception Perfluoroalkyl Substance (PFAS) Exposure on Reproductive and Perinatal Outcomes

Per- and polyfluoroalkyl substances (PFAS) are ubiquitous environmental toxicants that are associated with
adverse health outcomes including cancer and thyroid disease. The potential for PFAS exposures to negatively
influence human health has generated significant concerns in scientific, governmental and public realms. PFAS
are used in numerous consumer products, including nonstick cookware, textiles, and food packaging.
Importantly, these chemicals persist in the environment and have long elimination half-lives (~2 to 8 years) in
the human body, leading to near-universal exposure (some PFAS have been detected in the serum of more than
99% of the U.S. population). While limited human studies and evidence from animal models implicate PFAS
exposures in adverse reproductive and pregnancy outcomes including infertility, pregnancy loss, preterm birth,
and low birthweight, knowledge remains scarce, particularly for newer PFAS and PFAS mixtures. Further,
studies that examined perinatal outcomes such as preterm birth and low birthweight measured serum/plasma
concentrations during pregnancy, which may result in confounding by pregnancy-related physiologic changes.
Hence, there is a significant need for studies designed to measure PFAS exposure before conception. To better
define the impact of PFAS exposure on reproductive and pregnancy outcomes, and because environmental
exposures may also affect male reproductive success, we propose an innovative study to measure serum
concentrations of relevant PFAS analytes in both men and women before conception. We will leverage the
Environment and Reproductive Health (EARTH) Study (ES009718), a prospective preconception cohort of
couples recruited from a fertility clinic and followed through delivery. The aims of this proposal are to determine
the extent to which maternal and paternal preconception serum PFAS concentrations (individually and as PFAS
mixtures) are associated with: AIM 1) reproductive outcomes of fertilization, implantation, and semen quality
parameters; AIM 2) pregnancy outcomes of pregnancy loss and live birth; and AIM 3) birth outcomes of
birthweight and gestational age. Innovations include the assessment preconception exposure to emerging and
new PFAS and their mixtures in couples and the investigation of early reproductive and pregnancy outcomes
that have not been previously studied. The proposed study is highly time- and cost-efficient, as we will have
archived biospecimens and clinical data available for 834 nulliparous women and 435 men (435 couples). We
will recruit an additional 225 nulliparous women and 180 male partners to increase statistical power to a total of
615 couples. Our team includes expertise in male and female reproductive and environmental epidemiology,
PFAS exposure assessment, and advanced biostatistical and mixtures analysis methods. The proposed study
will have important scientific and public health implications by examining both maternal and paternal PFAS
exposure on reproductive, pregnancy, and birth outcomes, providing much needed data for evidence-based
policy to reduce PFAS exposure and harm.

Public health relevance
NARRATIVE Per- and polyfluoroalkyl substances (PFAS) are environmental toxicants of urgent scientific, governmental, and public concern over their near-universal human exposure and adverse health effects. Understanding the effect of PFAS exposure on a couple’s ability to conceive and carry a pregnancy to term is a critical research gap and an important public health goal. The proposed study is designed to determine the effects of paternal and maternal preconception exposure to PFAS on reproductive, pregnancy, and birth outcomes.